Effects of Exercise on Neurobiology, Social Cognition, and Systemic Inflammation in Autism

PROJECT SUMMARY/ABSTRACT
Autism spectrum disorder (ASD) has increased in prevalence considerably over the past several years and is
marked by social cognitive challenges, such as perspective taking. Such challenges can have significant
influence on one’s quality of life, with adolescence representing a particularly difficult phase due to the increase
in social demands that occur during this developmental period. ASD is associated with aberrant activity in brain
regions involved in the default mode network (DMN) as well as low-level systemic inflammation (i.e., increased
proinflammatory cytokine levels), both of which may contribute to the impaired social cognition observed in this
population. Exercise (EX) interventions have been shown to alter DMN function and reduce inflammation in
non-autistic samples, and preliminary studies suggest EX may enhance social functioning in autistic
individuals. Therefore, EX may be a promising, low-cost intervention approach for supporting social cognition
in autistic adolescents, and the proposed project is designed to test this hypothesis. Specifically, we aim to
determine if a 10-week EX intervention, relative to a social gaming control condition, can 1) enhance brain
response in DMN regions during a theory-of-mind (ToM) task; 2) improve social-cognitive functioning; and 3)
reduce levels of circulating proinflammatory cytokines in autistic adolescents. The project will deepen current
understanding of the neurobiological and immune mechanisms underlying EX interventions for autistic
adolescents, which is a population with high risk for sedentary behavior and few accessible, empirically
supported treatment options. Using functional magnetic resonance imaging (fMRI) and systemic inflammation
as biomarkers adds an innovative dimension to the project and may allow for more sensitive measures of
intervention-related changes than traditional behavioral markers. Data for the project will be derived from an
ongoing parent study led by Dr. Legget (Sponsor), who will primarily oversee Dr. Cosgrove’s (PI) research and
training during the fellowship period. Co-Sponsor Dr. Tregellas and a strong team of consultants will provide
additional, complementary expertise to Dr. Cosgrove’s training in the areas of neuroimaging, intervention
research, neurodevelopmental disorders, and immunology. Dr. Cosgrove has access to state-of-the-art
equipment and resources at the University of Colorado Anschutz Medical Campus that will allow her to
complete the proposed research and training. Altogether, the research and training goals planned for the two-
year fellowship period will support Dr. Cosgrove in developing as an independent researcher with expertise in
the application of clinical neuroscience methods to inform development of novel intervention approaches for
youth with ASD and related neurodevelopmental disorders, such as intellectual disability.

Public health relevance
PROJECT NARRATIVE As the prevalence of autism spectrum disorder (ASD) rises and accessible interventions remain limited, there is a critical need for the identification of neuroscience-informed treatment strategies. The proposed study will address this need by investigating the effects of a 10-week exercise intervention on key neurobiological and behavioral aspects of ASD, including social cognition and associated brain activity as well as systemic inflammation, in autistic adolescents. Findings from this project could therefore delineate mechanisms underlying the impact of exercise on autistic youth in addition to guiding the development of novel intervention approaches and supporting Dr. Cosgrove's career aspirations of establishing an independently funded research program focused on intellectual and developmental disabilities.